Los Angeles CRS for the MACS/WIHS Combined Cohort Study

Abstract
The UCLA Clinical Research Site (CRS) of the Multicenter AIDS Cohort Study (MACS) / Women's Interagency
‐ ‐ ‐‐
HIV Study (WIHS) Combined Cohort Study (CCS) proposes to continue to document clinical, immunologic,
‐‐ ‐
physiologic, behavioral, virologic, genetic and psychosocial changes in HIV infected and uninfected men who
‐‐
have sex with men (MSM). This includes proposed studies to document these changes in MSM recruited
‐
previously, as well as plans to recruit new untreated and recently treated HIV infected MSM (primarily African
‐‐
and Hispanic Americans), to maintain the cohort. The UCLA CRS will provide leadership and participation in
the working groups, CCS wide and local studies and research publications, as well as collaborative multi
‐
cohort studies, as it has since the inception of the MACS 35 years ago. The UCLA CRS has recruited a large
team of early career and established co investigators from a wide range of disciplines. These investigators
have developed, and are continuing to develop, innovative proposals to advance our understanding of co-
morbid conditions that arise in people living with treated HIV infection, as well as the pathophysiology,
immunology, genetics a‐nd bio-behavioral characteristics of treated and untreated HIV infection. The breadth,
enthusiasm, experience and innovation of the UCLA CRS investigators, combined with the experience and
commitment of the long term staff, and our leadership of several areas of HIV/AIDs research, will continue to
play an invaluable role in the success of the CCS over the next seven years.

Public health relevance
Project Narrative This is a proposal to continue the UCLA Clinical Research Site (CRS) of the Multicenter AIDS Cohort Study ‐‐ (MACS) / Women's Interagency HIV Study (WHIS) Combined Cohort Study (CCS), which studies clinical, ‐ ‐ ‐‐‐ immunologic, physiologic, behavioral, virologic, genetic and psychosocial changes in HIV infected and HIV uninfected men who have sex with men (MSM). The ongoing studies of the CCS will provide key information to advance our understanding of co-morbid and iatrogenic conditions occurring in people living with HIV infection (PLWH) receiving anti-retroviral therapy (ART), as well as inform the natural history of HIV at the molecular level, psychosocial determinants of disease and treatment compliance, and factors affecting optimal treatment of PLWH.